Health Services Research SWG

Modified Project Summary/Abstract Section

PROJECT SUMMARY – Health Services Research Scientific Working Group (HSR SWG)
The purpose of the Duke CFAR Health Services Research Scientific Working Group is to provide an interdisciplinary forum for health services researchers across Duke to engage in collaborative discourse with the goal of creating innovative approaches to addressing critical gaps in the delivery of comprehensive HIV care services to persons with HIV domestically and globally. In the prospective funding cycle, the scientific working group’s activities will prioritize three key cross-cutting areas to advance HIV care delivery: data science, implementation science and reciprocal innovation. HSR SWG will foster ongoing partnerships with academic entities within Duke with methodological expertise and resources in these priority areas (Aim 1). The SWG will build upon its existing collaboration with the Duke Institute for Health Innovation (DIHI), Duke CFAR’s primary data science partner to date. We will also develop new partnerships with Duke AI Health, Duke Health’s primary innovation hub for clinical informatics. The SWG will also leverage new resources within the Quantitative Sciences (QS) Core, to better inform health services delivery innovations that emerge from the forum with population-level data on social drivers of health, with the goal of creating more expansive and impactful interventions. The SWG will play a key role in growing Duke CFAR’s implementation science footprint by increased engagement with the Implementation Science Research Collaborative (INTERACT) within Duke PopHealth, and continued collaboration with IS experts in the SBS Core. In conjunction with the Duke Global Health Institute (DGHI), HSR SWG will also initiate discourse on successful concepts that can be applied to HIV care and prevention services delivery in the US from our many LMIC-based researchers within the group, through a moderated discussion series on reciprocal innovation. To better position the CFAR to align its research mission with the realities of unmet needs of PWH in Durham, the SWG will serve as the CFAR’s liaison to the Durham County Department of Public Health (DCDoPH). Together, the SWG and representatives from DCDoPH will develop a collaborative framework to synchronize efforts towards optimizing Durham’s HIV care continuum (Aim 2). The foundation of this framework will be the complementarity of DCDoPH population-level surveillance capability with Duke’s resources and expertise in clinical informatics and implementation science. Finally, the Duke HSR SWG will develop a formal partnership with a complementary health services research SWG at one of three Southern CFARs (Emory, Tennessee or UAB) to promote a cross-institutional exchange of ideas that will bolster novel and high-impact research initiatives towards the goal of providi healthcare to all PWH across the South (Aim 3). SWG activities will be led by a Director and Co-Director, with direct oversight from CFAR leadership. With an emphasis on the development of early-stage investigators (ESI) and assembling dynamic, multidisciplinary investigative teams, the SWG’s ultimate objective is to position the Duke CFAR as a leader in HIV health services research in the South and nationally.